Improving the diagnosis and outcome of diffuse alveolar hemorrhage in systemic lupus erythematosus

PROJECT SUMMARY
The variable clinical manifestations of SLE patients are largely unexplained. Although severe
diffuse alveolar hemorrhage (DAH) with pulmonary capillaritis is unusual in lupus, more than half
of patients with this complication die and focal lung hemorrhage occurs in 30-66% of patients.
Using a mouse model (pristane-induced lupus) developed in our laboratory, we will ask why
C57BL/6 (B6) mice are susceptible to pristane-induced DAH/vasculitis whereas BALB/c and
DBA/2 mice are resistant. DAH is initiated by lung endothelial cell (EC) injury followed by
recruitment of bone marrow-derived monocytes to the lung. We found that dysregulation of the
extrinsic coagulation pathway also is involved and that lung disease is abolished by early
treatment with MEK1/2 or ERK1/2 inhibitors. The overall hypothesis is that genetically-
determined lung microvascular EC injury evolves into DAH because of monocyte infiltration into
the lung and abnormal regulation of the extrinsic coagulation pathway. Aim 1 addresses
susceptibility to DAH. We will ask whether EC injury and bleeding are lung-specific and investigate
gene expression patterns associated with DAH by single-cell RNA-sequencing. Genes conferring
susceptibility/resistance to EC injury and bleeding be mapped in recombinant inbred BXD (B6 X
D2) mice. Aim 2 examines the MEK1/2-ERK1/2 pathway in pristane-induced DAH. We will define
the sequence of events leading to DAH and develop blood-based diagnostic tests for the
diagnosis of incipient DAH prior to the onset of bleeding. This is important, because the disease
process is irreversible once hemorrhage begins. We will look for tests that distinguish early DAH
(pre-bleeding) from other forms of lung injury, such as sepsis with acute respiratory distress
syndrome. Aim 3 translates what is learned in mice to human DAH. We hypothesize that the
disease process is similar except that the initial EC injury is caused by respiratory viral infections
rather than pristane. We will ask if a predisposition to lung EC injury determines susceptibility, as
in mice, and whether diagnostic approaches developed in the mouse model are relevant to human
DAH. Lung EC injury will be examined in SLE patients with influenza or COVID infection and the
role of mild bleeding disorders will be explored. The ability to diagnose incipient DAH (pre-
bleeding) may permit future therapeutic trials using FDA-approved MEK1/2 inhibitors, such as
trametinib, which are highly effective in pristane-induced DAH.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Although susceptibility to autoimmune diseases depends on genetic and environmental factors, we do not fully understand what determines disease severity. This project examines why certain strains of mice with lupus are susceptible to fatal lung hemorrhage and inflammation of the blood vessels while others are resistant. The data may allow for timely intervention to prevent lung hemorrhage, the ability to monitor disease activity more precisely, and ultimately the development of novel therapy and the means to better assess response to that therapy.